Role of integrin alpha 5 in the formation of the pharyngeal arch arteries

PROJECT SUMMARY
The aberrant formation of the Pharyngeal Arch Arteries (PAAs) results in severe and lethal forms of congenital
heart disease. The PAAs form through vasculogenesis, where an endothelial cell (EC) plexus invades the
pharyngeal arches before coalescing into patent PAAs. Our lab has shown that a majority of the ECs that make
up the PAAs derives from a population of mesodermal progenitor cells known as the Second Heart Field (SHF).
Additionally, our lab has shown that Integrin ɑ5 (Itgɑ5) expression within the Isl1-lineages, encompassing the
second heart field and pharyngeal endoderm and ectoderm, regulates the formation of the PAAs through
unknown mechanisms. Integrins are cell surface receptors that organize the ECM and relay ECM signals to elicit
cellular responses, including cell proliferation, survival, migration, and differentiation. Preliminary data suggests
Itgɑ5 regulates the number of SHF-derived ECs that give rise to the PAAs. We hypothesize that integrin ɑ5
expression in the Isl1-lineages regulates the number of SHF-derived ECs in the pharyngeal arches by mediating
SHF-progenitor cell survival and/or proliferation, migration, and/or differentiation. In Specific Aim I, we will
investigate this hypothesis using Itgɑ5f/- ; Isl1Cre mutant and Itgɑ5f/+ ; Isl1Cre control embryos, which carry the
Rosa26nTnG reporter. This reporter marks cells derived from the Isl1-lineages with the expression of nuclear GFP.
Utilizing this conditional knockout mouse model and immunohistochemistry, we will investigate the proliferation
and apoptosis frequencies, migration patterns, and differentiation capacity, of the Isl1-derived cells that give rise
to the ECs of the PAAs. My preliminary data additionally shows SHF-derived ECs crossing the midline in the
developing pharyngeal region within our mutants. During vertebrate development, cells in general do not cross
the midline ensuring proper left-right patterning. The ECM organization and programmed cell death response at
the midline create a barrier that stops cells from migrating across the midline. Because we know Itgɑ5 regulates
ECM organization we hypothesize that Itgɑ5 expression in the Isl1-lineages regulates SHF-derived EC patterning
through mediating the ECM organization and the programmed cell death response at the midline. We will
investigate this hypothesis in Specific Aim II, utilizing our conditional mouse model and immunohistochemistry.
We will compare the ECM organization and apoptosis frequency at the midline in control and mutant embryos.
Additionally, we will investigate the distribution of Isl1-derived cells at the midline during early embryogenesis
because if Isl1-derived cells are able to cross the midline in our mutants, the Isl1-derived cells that give rise to
the PAAs could be directed to the wrong side, resulting in aberrant PAA formation. The completion of the
experiments outlined in this proposal will provide insights into mechanisms involved in the development of the
PAAs and will therefore increase our understanding of how related congenital heart diseases arise, creating new
possibilities for the clinical detection, prevention, and treatments of these congenital heart diseases.

Public health relevance
PROJECT NARRATIVE The aberrant formation of the pharyngeal arch arteries leads to some of the most severe forms of congenital heart disease. Proper development of the pharyngeal arch arteries is dependent upon Integrin ɑ5 expression. Completion of the studies outlined in this proposal will provide insight into integrin ɑ5-dependent mechanisms that regulate the development of the pharyngeal arch arteries and in turn, lead to a better understanding of the etiology of congenital heart diseases related to the pharyngeal arch arteries.